Trachomatous Trichiasis and Predicting the End of Blinding Trachoma

Project Abstract
Trachoma remains an important global public health problem due to the millions of individuals
still affected by the disease and its blinding sequelae. The development of trachomatous trichiasis (TT), in-
ward turning eyelashes resulting from conjunctival scarring and/or entropion, is the point at which trachoma
becomes vision threatening. Around the world 3.2 million people suffer from TT which, if uncorrected, places
these individuals at high risk of blindness from corneal opacification (CO). Importantly, TT and CO can develop
after the active, infectious stage of trachoma has been eliminated. The World Health Organization has targeted
trachoma for elimination as a public health problem by 2020. Elimination is defined as when formerly endemic
districts demonstrate: i) a prevalence of follicular trachoma (TF) of less than 5% in children ages 1-9 years, and
ii) a prevalence of TT cases (not previously offered health services) of 0.2% or less in those 15 years or older.
Countries are successfully achieving the TF elimination targets; however, they are having difficulty meeting the
TT elimination goals, in part, because of incident TT cases after surgical intervention programs clear the
current backlog.
The lack of information on the time course of trachomatous conjunctival scarring (TS)
progression and TT development, especially as TF prevalence declines, contributes to the difficulty
programs face in allocating resources appropriately. Specifically, data are needed on the degree to which
the rate of TS and TT development and TS progression are affected by declining active trachoma.
The proposed study has three aims: i) to determine the rate of incident and progressive TS in a
formerly trachoma endemic area, and compare the rates with similar rates under a hyperendemic state, ii) to
determine the risk of incident TT when a district has eliminated TF and quantify this risk according to scarring
severity, and iii) to create a risk model for developing TT. To accomplish these aims, a longitudinal follow up
study will be undertaken in an established cohort of women in Kongwa district, where images of the upper
eyelid have been collected at baseline and 3.5 years later; we propose a seven year follow up to determine
ongoing incidence and progression of TS and new incident cases of TT. We will also create a disease model
for incident TT, using existing data, and test it under assumptions of TF elimination using newly collected data.
This trachoma research proposal has a high potential for impact for two reasons: i) it will create
knowledge of the time course and dynamics of disease progression from mild to severe TS and from TS to TT,
and the effect of TF elimination on this progression, and ii) it will result in the development of a model which
can forecast future incident TT rates based on known TS severity distribution within a district. The knowledge
gained from this proposal will allow trachoma elimination programs to appropriately allot limited surgical
resources after TF has been eliminated.

Public health relevance
Project Narrative The proposed study aims to: i) study how the rates of TS and TT development and TS progression are affected by declining TF prevalence, and ii) develop a prediction model for how incident TT rates will change given TF elimination and differing distributions of scarring severity in a district. This data can then be extrapolated to predict when new TT cases will be at, or below, the TT elimination target set by the World Health Organization. This information will assist countries in allocating limited resources and planning surgical services by providing information on a timeline for active surgical service intervention.